CANCER INFORMATION DISSEMINATION ANALYSIS CENTER (CIDAC)

The objective of the Cancer Information Dissemination and Analysis Center (CIDAC) covering carcinogenesis and cancer biology is to promote the exchange of technical information between cancer researchers on a worldwide basis by contributing to the active dissemination of research results in the areas of cancer etiology, epidemiology, virology, immunology, and biology.